Increasing access to opioid use disorder treatment by opening pharmacy-based medication units of opioid treatment programs

The US opioid overdose death epidemic has continued for over 20 years. Nonmetropolitan or rural areas with
low capabilities of opioid use disorder (OUD) treatment are associated with significantly elevated rates of opioid
overdose deaths. Many countries have increased OUD treatment access to reduce opioid morbidity by allowing
community pharmacy dispensing of methadone for methadone maintenance treatment (MMT). MMT has been
the most studied and longest utilized OUD treatment for about 55+ years. Federal regulations require MMT to
be provided through one of about 1,860 SAMHSA certified opioid treatment programs (OTPs). MMT is
considered less expensive (more affordable) and has higher treatment retention rates than buprenorphine
treatment for OUD. Thus, MMT is a preferred treatment option for many individuals with OUD.
However, the limited number of OPTs, limited capabilities of existing OTPs, and a long travel distance to an OTP
are major barriers to accessing MMT, especially for persons with OUD in rural and suburban areas. Pharmacists
are among the most trusted healthcare professionals. About 90% of Americans live within 5 miles of a community
pharmacy. Federal regulations allow OTPs to obtain approvals to establish methadone medication units (MUs)
at pharmacies (pharmacy MUs) to allow pharmacy administration and dispensing of methadone for MMT to
expand treatment. MUs are managed by OTP directors of the parent OTP who have oversight of patient care at
both the main OTP and MU location. MUs have been infrequently utilized in the US. Given the serious shortage
of OUD providers in the US to address the escalating opioid overdose death epidemic, there is an urgent need
to identify useful strategies of establishing MUs and to disseminate useful strategies of establishing MUs
nationally to OTP directors and community pharmacists in the US.
Built on the successful experience of the PI’s (Dr. Wu) research on developing physician-community pharmacist
collaborative care models to engage community pharmacists in providing buprenorphine treatment care to
patients with OUD (Wu et al., 2021a) and administration and dispensing of methadone for MMT (Wu et al.,
2021b), we will conduct a survey of OTP directors (n=586) and community pharmacists (n=586) to identify OTP
and community pharmacy facility/practice, individual, and contextual factors that are related to intentions to
establish a MU. Guided by a mixed methods explanatory sequential design, we will also conduct follow-up
qualitative interviews of a subsample of participants from each survey to further obtain in-depth data on MU
implementation barriers and facilitators in the US.
Due to the serious shortage of OUD providers and escalating rates of opioid deaths, this study is time-sensitive.
This study will be the first effort in the US to identify MU implementation barriers and facilitators from both OTP
directors and pharmacists. We will produce multiple peer-reviewed publications and an electronic toolkit for
establishing MUs to quickly disseminate the toolkit and publications to OTP directors and pharmacists nationally.

Public health relevance
Project narrative Due to the national opioid death epidemic and serious OUD physician shortages, this proposed study of identifying implementation barriers/facilitators of establishing pharmacy methadone medication units (MUs) is timely needed. We will produce multiple publications and an electronic implementation toolkit for establishing MUs to quickly disseminate the toolkit and publications to OTP directors and pharmacists nationally through the help of our consultants. The content of the toolkit will use the well-established Canadian model of pharmacy MUs as a framework and specify applicable information of WHAT, WHO, WHERE, WHEN, and HOW instructions for each element of standards of care of MU based on study findings and allowed US federal regulations to help pharmacists and OTP directors establish and practice MUs.